Modulation of ion channels by lipids and protein folding helper enzymes

Project Summary/Abstract (30 lines)
Transient Receptor Potential (TRP) channels are ubiquitously expressed across the human body where
they serve critical roles in sensing a range of external and internal stimuli. In addition to their well-
established contributions to acute and chronic pain, TRP channels also have been associated with kidney
disease, neurodegeneration, diabetes, and cardiovascular disorders, among others. Developing detailed
models of TRP channel function and regulation under physiological conditions therefore is essential to
defining their roles in health and disease.
TRP channels respond to a variety of stimuli and interact with many regulatory molecules in cells. Despite
significant advances in understanding the structure, function, and small-molecule modulation of these
channels, less information is available about how the general cellular environment influences and
controls TRP channels. Like many other ion channels, TRP channels consist of transmembrane domains
as well as cytosolic domains, which means that different parts of the same protein are exposed to very
different environments. This also means that the pool of potential interaction partners can be divided into
two categories: membrane-delimited interaction partners such as lipids, and cytosolic interaction partners
such as proteins. Our goal is to systematically dissect the contributions of each environment to the
polymodal regulation of TRP channels.
To identify physiologically relevant factors that modulate TRP channel activity, we will perform cell-based
experiments tailored to each of the two environments. We will then reconstitute TRP channels together
with these factors from purified components in vitro for detailed structure-function correlations. In contrast
to the complex cellular environment, this approach will allow us to establish tightly controlled and exactly
defined experimental conditions, which is necessary to develop quantitative models of TRP channel
regulation by other cellular components. Our interdisciplinary approach will combine molecular biology,
cellular imaging, biophysical and functional studies of purified proteins, and structural biology under
conditions closely mimicking physiological environments. With our work, we will contribute to a more
integrative understanding of TRP channel physiology, which may serve as a framework for the
development of novel pharmaceuticals.

Public health relevance
Project Narrative (3 sentences) In this program, we will study how the activity of specific ion channel proteins is modulated by cellular interaction partners. This is essential to describe how these macromolecules, which play central roles in pain, kidney disease, and arrhythmias among others, work under physiological conditions. Our work may provide a basis for the development of novel pharmaceuticals targeting these ion channels in specific disease states.